Alternative polyadenylation as a novel mechanism for diabetes

PROJECT SUMMARY
Obesity and the associated insulin resistance are the established risk factors for type 2 diabetes (T2D). Although
more than 90% of T2D patients are overweight or obese, only about 30% of obese people develop T2D. One
major determining factor for the development of T2D in obese patients is islet β−cell decomposition or failure,
resulting in relative insulin deficiency. It is well documented that islet failure has a strong genetic predisposition.
Genome-wide association study (GWAS) provides a powerful tool to associate genetic variants (SNPs) with T2D.
However, the vast majority of the diabetes risk SNPs from GWAS are found in the non-coding regions, posing
significant challenges to identifying the SNP-associated genes for T2D. 3’untranslated regions (3’UTR) are non-
coding sequences containing cis-regulatory elements (CRE), such as binding sites for miRNAs and RNA-binding
proteins (RBPs) that regulate mRNA fate and protein expression. Alternative polyadenylation (APA) at the 3’UTR
is an RNA-processing mechanism that generates mRNA isoforms with significantly different 3’UTR lengths with
distinct CREs. SNPs that regulate APA may lengthen or shorten 3’UTR, thereby altering gene expression and
function. We recently developed a novel 3’UTR APA quantitative trait loci (3’aQTLs) analysis tool to colocalize
disease-associated SNPs with APA. Using the 3’aQTLs tool, we found that the lengthening of 3’UTR of zinc
finger CCCH domain-containing protein 13 (ZC3H13) in the pancreas was highly associated with T2D. ZC3H13
is a key epitranscriptomic factor that forms an N6-methyladenosine (m6A) RNA modification writer complex with
methyltransferase-like 3 (METTL3) and methyltransferase-like 14 (METTL14). Both METTL3 and METTL14-
mediated m6A have been shown to be essential for β-cell function. Our preliminary data show that longer
ZC3H13 3’UTR reduced ZC3H13 protein expression without changes to mRNA levels. Knocking down ZC3H13
suppressed insulin production in the cultured β-cells. Furthermore, ZC3H13 heterozygous knockout mice
exhibited impaired glucose tolerance with reduced insulin levels when challenged with a high-fat diet. We,
therefore, hypothesize that the reduced ZC3H13 protein expression from 3’aQTLs-associated 3’UTR
lengthening contributes to the genetic predisposition of islet failure in T2D. We propose three aims to study what
SNPs cause ZC3H13 3’UTR lengthening, why ZC3H13 3’UTR lengthening reduces protein expression, and
how the reduced ZC3H13 protein impairs islet function. Aim 1: To identify the causal SNPs impacting APA of
ZC3H13 using functionally informed fine-mapping of 3'aQTLs. Aim 2: To determine the mechanisms by which
3’UTR lengthening reduces ZC3H13 protein expression. Aim 3: To investigate the mechanisms by which
reduced ZC3H13 expression impairs insulin production and islet function. Our studies will advance the field by
uncovering ZC3H13 APA as a novel genetic risk factor and elucidating ZC3H13-mediated epitranscriptomic
regulation as a novel mechanism for the impaired β-cell function in T2D.

Public health relevance
PROJECT NARRATIVE Although obesity is a major risk factor for type 2 diabetes, only about 30% of obese patients develop diabetes due to their genetic risk. The current proposal identifies genetic variants that reduce a gene called ZC3H13, leading to impaired function of insulin-producing cells. The results may help develop tools to identify high-risk obese patients for diabetes prevention and early intervention.